Germline Telomere Biology Defects in Pediatric and Young Adult Acute Myeloid Leuk

DESCRIPTION (provided by applicant): Dr. Maria Monica Gramatges is an Assistant Professor of Pediatrics at Baylor College of Medicine (BCM) and Texas Children's Cancer Center. She is currently supported on a K12 grant and is completing her Master's degree in Clinical Investigation. Her Clinical Research Mentor is Dr. Sharon Plon, a leading cancer geneticist, and her Basic Science Mentor is Dr. Alison Bertuch, a leading telomere biologist. Dr. Lisa Bomgaars and Dr. Michael Andreeff, faculty experts in clinical trial design and leukemia molecular biology, respectively, are on her advisory committee. Support from the K23 award will enable Dr. Gramatges to gain additional research skills and receive mentorship in authoring publications and developing research grants while performing her research project. Dr. Gramatges' goal is to become an independent investigator and leader in pediatric oncology translational research. In this application, Dr. Gramatges is studying the role of telomere biology in acute myeloid leukemia (AML) and treatment-related toxicities. Telomeres are repetitive DNA-protein structures at chromosome ends which protect chromosome integrity. Telomeres shorten with DNA replication, causing increasing cellular chemosensitivity and susceptibility to genomic instability. Telomere biology disorders, including dyskeratosis congenita, are due to germline missense and truncating sequence mutations in telomerase-associated genes and are associated with a spectrum of problems including aplastic anemia and a strong predisposition for myelodysplasia and AML. These sequence changes are also enriched in adults with hematologic malignancies, though no studies have explored their association with pediatric AML or treatment toxicities. Dr. Gramatges has generated significant preliminary data and developed collaborations at BCM, MD Anderson Cancer Center and through the Children's Oncology Group to answer two related questions (1) what proportion of children with AML harbor short germline telomeres and/or deleterious germline variants in telomerase-related genes and (2) does telomerase deficiency and/or short telomeres increase the likelihood of persistent bone marrow suppression and other toxicities characteristic of telomere biology disorders. She will test these questions by (1) clinically and functionally characterizing telomerase variants and determining their frequency in a local cohort of pediatric AML compared to controls (2) retrospectively comparing the proportion of deleterious telomerase variants and/or short telomere length in uniformly-treated pediatric AML patients with delayed vs. expected bone marrow recovery, and (3) prospectively determining the incidence of deleterious telomerase variants and short telomere length following chemotherapy in pediatric and young adult AML patients and correlating these results with specific treatment complications. Aim 3 is the first study to evaluate the effects of telomere biology on toxicities and outcomes in AML. Results of this research will support future work on a biological correlate to a consortium treatment study, and may result in screening, closer toxicity monitoring, and therapy modification, thereby reducing AML treatment-related morbidity and mortality.

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia (AML), comprising 20% of childhod leukemias, is treated with very intensive chemotherapy that results in moderate to severe treatment-related toxicities in 80% of patients, a proportion of which do not survive therapy. Our research studies genetic markers that characterize the subpopulation of children with AML who are at risk for severe treatment-related toxicities. Validation of these markers may lead to implementation of upfront screening of children with newly diagnosed AML, and, in cases where a mutation is discovered, a modified treatment regimen with closer monitoring of at-risk organ function in order to reduce the relatively high rates of treatment-related morbidity and mortality in this disease. ! ! ! ! __SpecificAimsTextDelimiter__ GERMLINE TELOMERE BIOLOGY DEFECTS IN AML - HYPOTHESES AND SPECIFIC AIMS The maintenance of telomere integrity in somatic tissues is critical to maintain genomic stability and support renewal of hematopoietic populations after exposure to damaging agents. This proposal is designed to investigate the incidence of germline defects in telomerase-associated genes in pediatric acute myeloid leukemia (AML) and the association of these variants and germline telomere length with predisposition for specific therapy-related adverse events. This work will both answer an important clinical question and serve as a vehicle to support my training as a clinician-scientist. The aims are designed to test specific but integrated hypotheses. Specific Aims 1A and 2A are included for completeness but are currently underway. Hypothesis 1: Germline deleterious variants in telomerase-related genes occur at a greater frequency in pediatric AML patients compared with frequencies observed in healthy controls and population databases, and are associated with specific clinical presentations. Specific Aim 1: To clinically and functionally characterize telomerase gene-related variants and determine their frequency in a local cohort of children with AML. Aim 1A: Comprehensively sequence a panel of four telomerase-associated genes in DNA from diagnostic bone marrow, with germline confirmation of variants by directed sequencing of remission samples. Aim 1B: Functionally characterize the identified variants in vitro (by telomerase activity and repeat addition processivity asays) and ex vivo (by primary fibroblast lifespan extension and telomere length stabilization assays), in order to compare the frequency of deleterious variants with a control population. Aim 1C: Independently review the medical records of the AML cohort to determine if findings characteristic of a telomere biology disorder are more common in those patients with deleterious variants. Hypothesis 2: Pediatric AML patients demonstrating delayed marrow recovery after chemotherapy have a higher proportion of deleterious germline telomerase variants and shorter germline telomere length than patients demonstrating expected recovery. Specific Aim 2: To clinically and functionally characterize telomerase gene-related variants in pediatric AML patients enrolled on Children’s Oncology Group protocol AAML0531 using the molecular methods described in Specific Aim 1, in order to compare the proportion of deleterious germline telomerase variants and relative telomere length between subjects who demonstrated either delayed or expected bone marrow recovery. Aim 2A: Identify telomerase-associated gene variants as described in Aim 1 for the delayed and expected marrow recovery groups. Aim 2B: Functionally characterize the identified variants in vitro and ex vivo as described in Aim 1. Aim 2C: Measure germline (remission) whole blood relative telomere length in samples obtained at the end of the second induction treatment phase using quantitative PCR. Aim 2D: Compare the proportion of germline deleterious telomerase gene-related variants and the average telomere length at end of second induction remission between the two recovery groups. Aim 2E: Review associated clinical information in the delayed recovery cohort to determine if subjects with deleterious variants demonstrated a higher incidence of grade 3 or 4 reportable toxicities compared with subjects in this delayed cohort without deleterious variants. Hypothesis 3: Pediatric and young adult AML patients with germline telomerase variants and shorter end of induction lymphocyte telomeres are more likely to develop severe treatment complications compared to those without variants and with longer telomeres. Specific Aim 3: To clinically and functionally characterize telomerase gene-related variants prospectively in pediatric and young adult AML patients using methods described in Specific Aim 1 and correlate these results with treatment complications. Aim 3A: Identify telomerase-associated gene variants as described in Aim 1. Aim 3B: Functionally characterize the identified variants in vitro and ex vivo as described in Aim 1. Aim 3C: Measure germline lymphocyte relative telomere length prospectively at the end of the first and second induction treatment phases using quantitative PCR. Aim 3D: Assess the association between deleterious telomerase variants and telomere length to treatment complications characteristic of a telomere biology disorder, specifically prolonged neutropenia and grade 3 or 4 mucosal, hepatic, or pulmonary toxicity.